Integrative omics of preeclampsia in TOPMED and maternal cardiovascular health

Preeclampsia (PE), the development of new-onset hypertension and proteinuria after 20 weeks gestation, is a
severe pregnancy-specific disorder mediated by the placenta that affects 5% of all pregnancies. Women with
prior PE have an 2-4 fold increased lifetime risk of cardiovascular disease, including ischemic heart disease and
stroke. The underlying etiology of PE remains poorly understood; consequently, predictive and therapeutic
options remain limited. PE has a substantial heritable component estimated at 55-60%, with both maternal and
fetal contributions, estimated at 30-35% and 20%, respectively. Progress in understanding PE genetics has
lagged other disorders due to: the involvement of two genomes (maternal and fetal), disease heterogeneity, the
exclusion of obstetric phenotypes from many large cohort studies, and the lack of PE collections of adequate
sample size for power to identify genetic risk loci. Beyond genetics, profiling of PE using other omic strategies
has identified transcriptomic, proteomic, and metabolomic alterations that precede disease. However, PE cohorts
with multiple omics on the same well-phenotyped individuals are lacking. To address these challenges and
advance understanding of PE pathophysiology, we propose to leverage TOPMed data in the “Boston-Colombia
Collaborative Adverse Pregnancy Outcome study” which capitalizes on two large, multi-ethnic pregnancy
cohorts, LIFECODES (Boston) and GenPE (Colombia). LIFECODES is an ongoing longitudinal pregnancy
cohort (2009–present, N >3000 pregnancies, 152 PE cases) with maternal samples from each trimester of
pregnancy and delivery samples. GenPE is a Colombian study (2000 – 2012, N = 3260 cases, 4331 controls)
created to identify maternal and fetal genetic risk variants. Specifically, for this proposal, we will leverage
TOPMed X01 funded whole genome sequencing (WGS) on the entire LIFECODES and GenPE cohorts, as well
as in-depth multi-omic profiling (metabolic, circulating microparticle proteomic and transcriptomic) on all
antepartum plasma samples in matched PE case-control samples within LIFECODES, expected to be available
before the grant start date. We propose three specific aims. First, we will perform gene discovery for
preeclampsia using common variant, rare variant, gene based and maternal-fetal interaction analyses. Second,
we will leverage longitudinal in-depth multi-omic profiling on all antepartum plasma samples in matched PE case-
control samples to identify molecular subtypes of PE and link these to known and novel genetic variants. Third,
we will test if polygenic risk scores for PE, supplemented by longitudinal molecular and clinical phenotypes,
predict maternal morbidity at delivery and future cardiovascular disease. Taken together, analysis of this multi-
omics project of PE in TOPMed, together with replication in independent cohorts, will yield novel insights into the
etiology of preeclampsia. As adverse pregnancy outcomes dramatically increase the risk of future
cardiometabolic disease in affected women, improved mechanistic understanding of pregnancy-related
disorders will enhance strategies for improving women’s health and preventing future cardiovascular disease.

Public health relevance
Preeclampsia is a severe disorder that affects 5% of all pregnancies and is characterized by elevated blood pressure and increased urinary protein; treatment options remain limited. Here, we propose to leverage a large multi-ethnic study with genomic and intermediate molecular phenotypes (metabolites and circulating microparticle transcripts and proteins) to identify maternal and fetal determinants of preeclampsia and causal biologic pathways altered in pregnancy. Since preeclampsia is a leading cause of maternal mortality and preterm birth worldwide, and increases women’s future cardiometabolic disease risk 2-4-fold, improved preventative and therapeutic interventions based on underlying mechanisms have a great potential to positively impact public health.